Molecular regulation of the capillary barrier in acute critical illness

Project Summary
Capillary leak is common in acutely critically ill children. Although no gold standard definition exists, it is clinically
recognized as new or worsening organ failure despite appropriate cardiovascular resuscitation. Unfortunately,
little has been learned of the pathophysiologic processes despite decades of struggling at the bedside of volume
overloaded children with multiple organ dysfunction syndromes. Treatment is limited to intensive supportive care
for failing organ systems. Less confusion exists in vitro, where leak around cultured human microvascular
endothelial cells (EC) is identified as disruption of intercellular tight junctions (TJs) with functional changes in
monolayer permselectivity. Such changes may be modeled in the EC response to cytokines, including those
known to be elevated in the plasma of critically ill children. However, targeting specific cytokines has repeatedly
failed to improve patient outcomes. Our overarching hypothesis is that while a great many leak-producing
cytokines may be elevated in acute critical illness, there are only limited EC responses and that final
common signaling pathways result in leak either between (para-) or through (trans-) ECs are therapeutic
targets. However, the relative contributions of trans- and paracellular leak to the clinical manifestations of leak
(i.e., organ dysfunction) and the pathways that cause them are incompletely understood. We will focus on targets
we identified upregulated in ECs isolated from critically ill children (collected from vascular access insertion
equipment and immediately analyzed by single-cell RNA-sequencing). This unique data set has identified
candidate regulatory molecules associated with paracellular leak and oncostatin M (OSM) as a novel mediator
of transcellular leak. We will test the contribution of these targets to leak in our culture models of TJ-forming
human microvascular ECs from a healthy donor (both male and female) skin and lung using trans-endothelial
electrical resistance, macromolecular flux assays, morphological analyses, molecular engineering, and immuno-
chemical tools. Aim 1 will utilize tumor necrosis factor (TNF) to model paracellular leak to test the hypotheses
that ArhGEF15, ArhGAP21, and -26 regulate RhoB activity, promoting junctional disassembly via downstream
kinases directly acting on TJs and amplified new gene transcription. We have also discovered that formoterol,
but not other β2-adrenergic agonists, inhibits TNF-induced leak and will investigate potential mechanisms. Aim
2 will test the hypothesis that OSM induces vesicle-associated JAK3/STAT3 signaling resulting in transcellular
leak, which also depends on new gene expression, and investigate how formoterol reduces OSM-induced leak.
Finally, in Aim 3, we will determine if the specific pathways identified in Aims 1 and 2 are recapitulated in intact
human capillaries in vivo using human skin xenografts in mice and ex vivo using machine-perfused human lungs.
The proposed research will advance our fundamental understanding of how capillary leak occurs in acutely
critically ill children and evaluate an FDA-approved therapy re-targeted to the endothelium to prevent or reverse
capillary leak, greatly improving the care of our sickest patients.

Public health relevance
Project Narrative Endothelial cell (EC) alterations that occur in critically ill children can cause capillary leak with severe clinical consequences, but the mechanisms by which the capillary barrier becomes disrupted are unknown, limiting the development of effective therapies. We have identified changes in human ECs isolated from children presenting with multiple organ failures who later develop capillary leak associated with para- and transcellular leak and identified specific pharmacologic inhibitors. We will elucidate the mechanisms of these changes in appropriate culture models of human capillary ECs and validate our cell culture findings using an in vivo model of human skin capillaries implanted and perfused in immunodeficient mouse hosts in ex vivo perfused human lungs.